Administrative Core

Project Summary – Administrative Core (Core A)
The proposed research program will investigate outcome disparities in Latino children and adolescents with
acute lymphoblastic leukemia (ALL). The Program is built on a multi-institutional consortium, the Reducing Ethnic
Disparities in Acute Leukemia (REDIAL) Consortium, comprising 6 pediatric cancer centers in the southwestern
United States, with large proportions of Latino children and adolescents with acute lymphoblastic leukemia (ALL).
Core A, the Administrative Core, will oversee and coordinate all entities of the Program Project to ensure maximal
synergy of the Cores, Projects, and the Developmental Research Program (DRP). This Program includes: Core
B, the Biospecimen Processing and Storage Core; Core C, the Biostatistics and Data Management Core; Project
1, investigating etiology and impact of ethnic disparities in therapy-associated hepatotoxicity; Project 2,
investigating ethnic disparities in methotrexate neurotoxicity; and a DRP, to support the development of
innovative pilot projects. By facilitating employment, training, regulatory compliance, internal and external
communication, and financial management of the Program Project, Core A will maximize the productivity and
efficiency of all participating Projects and Cores. Under the leadership of Co-Directors Drs. Karen Rabin and
Philip Lupo, Core A will be responsible for overseeing the conduct of the research at the various sites, including
the regulatory, financial, and human resources aspects. Core A will also ensure regular internal communication
among investigators and sites and organize external communication with leaders in the field, the scientific
community, and patient advocacy organizations. Core A will (1) oversee all human resource management
responsibilities, including creation of job descriptions and the hire, evaluation, and replacement of personnel
locally and at the Consortium sites; (2) provide regulatory management and governance to the Program
Project, including tracking regulatory submissions/approvals and assisting with necessary training of research
staff; (3) control expenditures and maintain budget information for all Projects, Cores, and Consortium sites;
and (4) facilitate internal and external communication among all participating Project Leaders, Core Directors,
and sites through regular meetings to ensure adequate enrollment rates, identify and solve logistical issues, and
present updates on the progress of the research. An Internal Advisory Board (IAB) and External Advisory Board
(EAB) will be established, both of which will include leaders in the fields of pediatric leukemia biology, genomics,
epidemiology, supportive care, and patient advocacy, including two leaders of funded Specialized Programs of
Research Excellence (SPOREs). There will be twice yearly meetings of the IAB and an annual virtual meeting
of the EAB, during which the Project Leaders and Core Directors will present results for feedback and evaluation.
In summary, the Administrative Core will ensure that all aspects of the proposed research program are conducted
in accord with the highest standards of organization, documentation, communication, and fiduciary responsibility.

Public health relevance
Project Narrative Core A, the Administrative Core, will oversee and coordinate all entities of this Program Project to ensure maximal synergy, productivity, and efficiency of all participating Cores, Projects, and the Developmental Research Program. Under the leadership of Co-Directors Drs. Karen Rabin and Philip Lupo, Core A will be responsible for overseeing the conduct of the research at the various sites, including regulatory, financial, human resources, and internal and external communication. The Administrative Core will ensure that all aspects of the proposed research program are conducted in accord with the highest standards of organization, documentation, communication, and fiduciary responsibility.